MRI of epicardial adipose tissue composition: development of methods and application to heart failure with preserved ejection fraction

Project summary
This proposal seeks to develop improved cardiac MRI (CMR) methods to quantify epicardial adipose tissue
(EAT) composition and to demonstrate the advantages of EAT composition imaging (a) in advancing our
understanding of the relationship between EAT and heart failure with preserved ejection fraction (HFpEF) and
(b) for understanding mechanisms of and guiding medical therapy in HFpEF. EAT is the visceral adipose
tissue situated immediately adjacent to the myocardium which is in direct contact and shares a microcirculation
with both the myocardium itself and the coronary vessels. In healthy conditions EAT plays beneficial roles as a
source of fuel for cardiomyocytes and by secreting anti-inflammatory adipokines. However, in obesity EAT
accumulates, becomes proinflammatory, and promotes coronary vascular/microvascular inflammation,
oxidative stress, and diffuse and perivascular fibrosis, contributing to atrial fibrillation, epicardial and
microvascular coronary artery disease, and HFpEF. While imaging of EAT quantity has shown clinical value,
basic studies implicate the EAT fatty acid composition (FAC) in the activation of proinflammatory signaling
pathways. Consistent with the basic science, our preliminary data suggest that CMR of EAT FAC is a
modifiable biomarker of proinflammatory EAT with greater clinical utility than imaging of EAT quantity. We
recently developed the first method for quantifying EAT FAC in human subjects, utilizing a rate-6 accelerated
radial 2D multi-echo gradient-echo breathhold acquisition with a local low rank reconstruction. In this project
the first specific aim is to develop a rapid free-breathing 3D EAT FAC MRI method that reduces motion-related
artifacts, increases coverage, and facilitates higher spatial resolution and improved FAC reproducibility.
The second specific aim is to show that EAT FAC is more strongly associated than EAT volume with
cardiometabolic HFpEF. In this context, individuals with known or suspected HFpEF will undergo CMR,
echocardiography, and other testing to (a) diagnose cardiometabolic HFpEF; (b) characterize features
associated with the severity of HFpEF; and (c) assess EAT volume and FAC. We will determine if EAT FAC is
more strongly associated than EAT volume with HFpEF and with features associated with the severity of
HFpEF. The third specific aim is to show, in the context of cardiometabolic HFpEF and pre-HFpEF, (a) that
GLP-1 receptor agonism with semaglutide (SEMA) shifts the EAT FAC to a less proinflammatory profile and (b)
that baseline EAT FAC is a stronger predictor than EAT volume of improved cardiovascular function due to
SEMA. Cardiometabolic HFpEF and pre-HFpEF subjects will undergo echocardiography and CMR with EAT
FAC at baseline and after 2 months to serve as a self-control. Subjects will then undergo repeat imaging 5
months after the initiation of SEMA. The change in FAC after treatment with SEMA will be compared to the
change in FAC prior to SEMA. Data will be analyzed to show that SEMA changes EAT FAC, and that baseline
EAT FAC is a stronger predictor than EAT volume of improvements in severity of HFpEF.

Public health relevance
Project Narrative Heart failure with preserved ejection fraction (HFpEF) represents approximately half of all heart failure cases; however, our understanding of HFpEF is incomplete and therapy development is at a nascent stage. In obesity, the fat around the heart (the epicardial adipose tissue (EAT)) becomes proinflammatory and promotes coronary microvascular inflammation and oxidative stress, contributing to atrial fibrillation, microvascular dysfunction, and HFpEF. This project seeks to develop improved imaging methods to quantify EAT composition and to demonstrate the advantages of EAT composition imaging (a) in advancing our understanding of the relationship between EAT and HFpEF, and (b) for understanding mechanisms of and guiding medical therapy in HFpEF.